NATIVE &RECOMB MEMBRANE PROTEIN TO DETERMINE FUNCT &DRUG DESIGN: HIV INTEGRASE

Our laboratory focus is to reveal functional mechanisms of integral membrane proteins at the level of chemistry and atomic structure for impact on drug design. Membrane proteins include bacteriorhodopsin, ATcase-bacteriorhodopsin fusion protein, nicotinic acetylcholine receptor, serotonin receptor, thrombin receptor, a NNa+/K= ATPase, and CHIP 28. Soluble proteins include thymidilate synthetase, creatine kinase, colicin, d-UMP hydroxymethylase, SIV/HIV protease, HIV integrase, B. thuringiensis toxins (Cry2a, Cry1c, Cyta), and a designed 4-helix bundle. Synthesized peptides include those used for antibody production, enzyme substrates and ligands, and peptide-based 'peptitergents' which assist in solubilization and crystallization of membrane proteins. Following isolation, expression or synthesis, these proteins and peptides will be purified and characterized prior to 3-D crystallization. To facilitate characterization and crystallization, mass spectrometry will be used to assay purity, mass, and post-translational processing events. In addition, these efforts will develop purification procedures of hydrophobic proteins and peptides in environments amenable for mass spectrometry.